Supplement to Framework for Advances in Reprogenomics Ethics & Regulation (FAIRER)

ABSTRACT
The FAIRER study is designed to develop a framework for the ethical conduct of clinical trials of reproductive
genomic interventions, particularly focusing on the research participation of pregnancy-capable individuals.
This supplement to the FAIRER study will address unique ethical and social issues in trials involving research
participants from sexual and/or gender minorities (SGM). The motivations and considerations of SGM
regarding reproductive genomic interventions, while sharing common features with those of cisgender and
heterosexual participants, likely also differ in significant ways. Physiological, genetic, and social differences
between cisgender participants, transgender participants, and those with differences of sexual development
(DSD) may necessitate changes in trial design and safety considerations. Finally, SGM have historically
experienced marginalization in medical settings, particularly with respect to access to and utilization of assisted
reproductive technologies, that impact trust relationships in biomedical research. In order to build an ethical
framework that considers the needs and interests of all potential participants in reprogenomics clinical trials,
this project has the following Aims: (1) Incorporate considerations unique to individuals identifying as sexual
and/or gender minorities (SGM) into an ethical framework for reprogenomics research, with emphasis on the
health and well-being of pregnant and potentially pregnant participants and their future offspring; and (2) Build
the perspectives and expertise of SGM individuals and experts in SGM healthcare and research into our
ethical framework and the stakeholder-informed toolkit to guide IRBs and researchers engaged with
reprogenomics. To accomplish these Aims, we will conduct a scoping review of literature on SGM
considerations in family-building; interview professionals with expertise in SGM health to draft an ethical
framework that addresses issues relevant to SGM clinical participation; and conduct two focus groups with
individuals from SGM communities to discuss and receive feedback on the draft framework. These strategies
will enhance our larger project and increase the relevance of its results and deliverables to all stakeholders
who may be involved in future human research in reprogenomics.

Public health relevance
PROJECT NARRATIVE Our current FAIRER R01 has undertaken groundbreaking research to develop an ethical framework for the inclusion of pregnant individuals in studies of human germline genomic modification (reprogenomics) to structure human trials in ways that meaningfully advance the science without causing undue harm to those they are meant to benefit. The objective of the parent project is to establish an ethical framework for reprogenomics research that specifically addresses the needs and interests of diverse populations of pregnant and pregnancy-capable participants. This administrative supplement will increase the impact of the parent FAIRER R01 by fully integrating considerations and perspectives of sexual and/or gender minorities (SGM), an underrepresented population in research, into the ethical framework and end products developed for IRBs, scientists, and funding organizations.